Effects of Chronic Catecholamine Exposure on Post-burn Scarring

DESCRIPTION (provided by applicant): Each year, 700,000 - 900,000 burn patients develop severe hypertrophic scarring (HS). These scars restrict movement, are painful, and severely limit the quality of life for these patients. Our group has recently observed that propranolol (PPL), a non-specific β ?adrenergic receptor (βR) antagonist, improves wound healing (WH) and reduces HS in severely burned children. Preliminary experiments demonstrate that burn injury not only drastically elevates catecholamine levels in the skin, but also alters the expression of βARs in the scar, and leads to changes in ? and ?AR mediated signaling in fibroblasts from HS. Importantly, PPL attenuates these changes. The effects of chronic catecholamine exposure or long-term ?lockade on scarring in the severely burned have also not been studied. The overarching hypothesis of this project is therefore that delayed WH and severe HS result from chronic stimulation by catecholamines that disrupt normal βR expression and function, and that ?lockade improves WH and decreases HS by correcting these catecholamine-induced deficits. We propose that impaired WH related to chronic catecholamine exposure is due to heightened inflammation in the wound and scar, and that defects in βR signaling lead to increased fibrosis (characterized by greater deposition of keratin and collagen), resulting in severe HS. We further hypothesize that long-term ?lockade decreases local inflammation and restores βR signaling, improving WH and reducing HS. To test this hypothesis, we will by pursuing three Specific Aims investigate the molecular events occurring in the skin and scars of the severely burned treated with and without propranolol in two placebo-controlled trials of PPL use to reduce the post-burn hypermetabolic response. Aim 1 is to determine the effects of chronic catecholamine exposure and ?lockade on WH and HS by measuring tissue catecholamine levels, wound healing, scar severity, range of motion, and genetic polymorphisms related to the response to ?lockade. Patients will receive either short- or long-term ?lockade to determine which results in better clinical outcomes. Aim 2 is to quantitate the effects of ?lockade on scar composition, by determining cellular composition and βR expression in the wound and scar, utilizing innovative metabolic tracer studies to measure real-time collagen and keratin turnover rates, and measure pro-and anti-fibrotic factors that regulate fibrosis. Aim 3 is to determine the effects of ?lockade on βR expression, activity, and binding partners in dermal fibroblasts from HS and the same patients' non-burned skin. We will use primary cell cultures to study cellular signaling responses after stimulation wit catecholamines or ?lockade with ? and ?specific antagonists, in addition to PPL. Development of a therapy to improve post-burn wound healing and decrease scarring would improve the quality of life for severely burned patients and reduce the long-term cost of their surgical and psychological care. Therefore, determining whether long-term mitigation of catecholamine-triggered βR signaling improves WH and reduces HS in severely burned patients is a high priority.

Public health relevance
PUBLIC HEALTH RELEVANCE: About 70-90% of severely burned patients develop painful and itchy hypertrophic scars that severely limit motion, reduce quality of life, and are most effectively treated through costly and painful surgical removal. We recently discovered that chronic stimulation by catecholamines (the fight-or-flight hormones) may impair wound healing and increase post-burn hypertrophic scarring, but that �lockade with propranolol may improve wound healing and reduce hypertrophic scarring. Understanding the mechanisms underlying aberrant wound healing and scarring, and their reversal by propranolol, will lay the foundation to develop additional anti-scarring therapies for the severely burned.